Heme and hemoglobin utilization by Mycobacterium tuberculosis

Project Summary - Heme and hemoglobin utilization by Mycobacterium tuberculosis
Mycobacterium tuberculosis (Mtb) is of one of the most important bacterial pathogens. Iron is
essential for growth of Mtb, but iron is efficiently sequestered in the human host. Hemoglobin is
by far the most prevalent iron source in the human body and is often preferred by bacterial
pathogens. Recently, we identified proteins that are essential components of an unprecedented
heme and hemoglobin utilization system in Mtb. Interestingly, these novel heme-binding
proteins are also required for utilization of hemoglobin indicating that heme is released from
hemoglobin at the cell surface of Mtb by an unknown mechanism and then transferred to the
heme uptake system. This proposal aims to elucidate the molecular mechanisms of heme and
hemoglobin utilization by Mtb. This project will lead to a better understanding of how Mtb gains
access to iron during infection. To achieve these goals we employ state-of-the-art genetic,
biochemical, biophysical and structural methods.

Public health relevance
Project Narrative - Heme and hemoglobin utilization by Mycobacterium tuberculosis Mycobacterium tuberculosis causes tuberculosis, a highly infectious disease which kills millions of people world-wide. Iron is an essential element for M. tuberculosis. The aim of this proposal is to reveal the molecular mechanism how M. tuberculosis obtains iron from heme and hemoglobin, the most prevalent iron sources in the human body.